2025 Cell Biology of Megakaryocytes and Platelets Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on the Cell Biology of
Megakaryocytes and Platelets is the premier international meeting in the field. Every other year, this conference
brings together established and junior investigators, graduate and postdoctoral trainees, as well as interested
industry scientists to communicate and discuss unpublished data that are critical to the development and
disorders of the megakaryocyte lineage. The 2025 conference, the 10th of this GRC/GRS series, will provide a
collegial and open setting to facilitate networking, promote discussion and foster collaborations among current
and emerging leaders of the field. The long-term scientific mission of the conference is to bridge the gap between
researchers working on various aspects of the lineage, including hematopoietic stem cells, megakaryocytes, and
platelets. This mission is more relevant than ever, as the interdependence between each cell type becomes
increasingly clear, such as the role of megakaryocytes in stem cell development, and the impact of inflammation
on megakaryocyte growth and platelet production. More specifically, the 2025 conference aims to:
1. Highlight the extraordinary progress being made in our understanding of platelet function in the context of
hemostasis, thrombosis, and inherited platelet disorders.
2. Discuss the latest unpublished research on the engineering of in vitro generated platelets.
3. Link the megakaryocyte/platelet lineage to immunity and inflammation.
4. Redefine the lineage and the bone marrow niche.
5. Examine state-of-the-art studies that push the field into new directions, including molecular mechanisms
regulating platelet production and vascular interactions.
To encourage interaction between researchers, we have combined megakaryocyte and platelet presentations in
the same sessions. In addition, 10 high ranking abstracts will be selected for short oral presentations throughout
the conference.

Public health relevance
NARRATIVE Platelets are blood cells essential for blood clotting and would healing, and they also play an important role in the development of thrombosis, such as those in heart attacks and strokes. Platelets and their precursor cells called megakaryocytes are also involved in immunity, vasculature, inflammation, tumor metastasis, and other physiologies of the blood system. The overall goal of the Gordon Research Conference on the Cell Biology of Megakaryocytes and Platelets is to improve the understanding, prevention, and treatment of hematological and cardiovascular diseases.